MITOCHONDRIAL AND ALZHEIMER DISEASE IN RARE ISOLATED POPULATIONS

No research subjects are admitted under this protocol. It utilizes the Molecular Cell Biology Laboratory only. The Lab Supervisor transforms and stores immortal Epstein-Barr virus lymphoblast cell lines from patient samples sent directly to the Lab. The cell lines then serve as a permanent DNA/RNA resource, as well as an in vitro model system for molecular genetics investigations.